Northern Pacific Global Health Leadership, Education, and Development for Early-career Researchers (NPGH LEADERs)

Over the past ten years, our consortium Universities in Hawaii, Indiana, Michigan, Minnesota, and Washington
have provided research training to 221 Fogarty Global Health Fellows and Scholars, who to date have
generated 866 publications. With this competitive renewal, we propose to expand training activities aimed at
increasing the likelihood of trainees becoming independent global health scientists and leaders. We have
modified our consortium name to reflect this new emphasis: Northern Pacific Global Health Leadership,
Education, And Development for Early-career Researchers (NPGH LEADERs). We propose to continue
partnerships based in nine countries: Kenya, Uganda, Ghana, Cameroon, Liberia, Peru, Thailand, Nepal, and
India. To achieve our objective of developing the next generation of independent global health scientists and
leaders, we will offer 12-month research and leadership training with the following specific aims: Aim 1: To
ensure excellence in scientific inquiry, trainees will complete a comprehensive curriculum in global health
research, including how to frame novel, relevant, and feasible scientific questions, prepare detailed scientific
protocols, and plan for the implementation of a mentored research project in a low- or middle-income country.
Aim 2: To address the challenges of research implementation in a low-resource setting, trainees will follow an
explicit, expedited, supported, and mentored progression from research planning to pragmatic implementation
and process management. Aim 3: To prepare trainees for careers as independent scientists and to excel in
both leadership and management, we will support trainees in development of individualized “road maps” to
define the research, management and leadership skills necessary for their transition into independent
investigators. We will also expand alumni support for alumni to further strengthen the scientific and leadership
skills necessary for transitioning to the next generation of independent global health scientists. The four U.S.
universities have committed cost-sharing funds totaling $565,000 to increase recruitment and retention of
promising trainees and support a second year of fellowship for the most productive fellows. We anticipate
supporting at least 10 trainees each year, for a total of 50 trainees over the five year grant period; 60% of
trainees will be at the U.S. postdoctoral level and 40% will implement HIV-related research projects.

Public health relevance
NIH-funded global health research benefits populations in the United States by advancing understanding of diseases and health conditions affecting people worldwide, including many present in the U.S. Studying conditions such as diabetes, heart disease, and antimicrobial resistance in diverse global settings provides researchers with broader data and varied contexts in which they occur, leading to more robust and effective treatment and prevention strategies. These global insights enable the development of more robust, scalable treatment and preventive strategies to improve healthcare outcomes for Americans, especially in communities experiencing similar environmental, genetic, or socioeconomic factors influencing health. In addition, global health research funded by the NIH contributes to building strong international networks of scientific collaboration, which enhance the U.S.’s ability to monitor and respond to emerging health threats. This collaborative international infrastructure supports early detection of health risks that may eventually impact the U.S., providing valuable time for preparation and response. Furthermore, training and capacity-building efforts supported by NIH globally often involve U.S.-based researchers and institutions, strengthening the country’s scientific workforce and keeping it at the forefront of medical innovation and frontline defense for domestic security.